Acquisition of OrbiTrap Eclipse w/FAIMS mass spectrometer

Project Summary/Abstract:
This application is for funds to purchase a Thermo Scientific Orbitrap Eclipse w/FAIMS mass spectrometry
system for Fred Hutchinson Cancer Research Center’s Proteomics Facility. The facility supports the Fred
Hutchinson/University of Washington Cancer Consortium which is made up of these two institutions and research
partners at Seattle Children’s Research Institute and the Seattle Cancer Care Alliance and has a combined
annual NIH grant base exceeding $300 million. Our facility has been operating for 20 years and we have a
combined 75+ years’ experience in the operation, maintenance, and management of mass spectrometry
instrumentation, and in the design and analysis of proteomics experiments. Current discovery-based mass
spectrometry instrumentation in the facility is running at capacity causing long wait-times for service. Additionally,
outdated instrumentation in the facility it being used for multiplexed proteomics and high-sensitivity experiments,
but that instrumentation lacks the sensitivity and quality needed to properly support those experiments. In this
application we are requesting the Orbitrap Eclipse w/FAIMS to replace a 9-year old Orbitrap Elite in order to
achieve two goals: the first is to increase sample capacity/throughput of our facility to reduce wait-times and the
second is to replace the outdated instrumentation to ensure discovery-based proteomics research is carried out
on technically appropriate instrumentation. With TMT-based discovery experiments and analysis of major
histocompatibility complex I (MHC-I) peptides being the most frequent requests for proteomics services, the
Orbitrap Eclipse w/FAIMS is the most suitable instrument based on the instrument’s 1) scan speeds up to 40 Hz
in the Orbitrap and 45 Hz in the ion trap for thorough sampling of complex peptide mixtures, 2) high ion
transmission and ion mobility separations for high sensitivity, 3) real-time database searching for accurate
multiplexed quantification, 4) new segmented quadrupole with hyperbolic rods for more accurate TMT
quantification, and 5) novel active beam guide for enhanced sensitivity and robustness. This state-of-the art
instrument would immediately support the research of 11 investigators funded by 14 NIH grants that include
investigations identifying the proteins and protein modifications that regulate chromosome segregation, defining
molecular pathways associated with energy balance, determining how mutations in RNA spliceosome proteins
alter cellular phenotypes, understanding virulence factors associated with Group B streptococcus infection,
identifying proteins that influence chimeric antigen receptor’s efficacy and side effects, and discovering protein
biomarkers in ovarian cancer, breast cancer, and acute myeloid leukemia. Other projects aim to rapidly identify
major MHC- I peptides to better understand immune system response, develop targeted therapies against
myelodysplasia, leukemias, and other cancers driven by human papilloma virus infection, and better understand
hematopoietic stem cell transplant outcomes in African American patients.

Public health relevance
Project Narrative: This proposal requests funds for instrumentation to advance the ability of scientists in the Fred Hutch/University of Washington/Seattle Children’s Research Institute Cancer Consortium to study proteins from tissues, cells, and blood, that are in normal and diseased states. This will enable a better molecular-level understanding of cancer and other serious diseases, thereby advancing new diagnostic and therapeutic modalities to improve patient outcomes.